Immune, hormonal, and muscle mitochondrial determinants of recovery in Acute Respiratory Distress Syndrome survivors

PROJECT SUMMARY
Prior to COVID-19, over 150,000 Americans survived Acute Respiratory Distress Syndrome (ARDS) each year.
To date, more than 500,000 Americans have survived COVID-19 ARDS. At least half of ARDS survivors have
persistent muscle weakness that results in increased disability, healthcare costs, and mortality. There are no
targeted therapies to improve muscle strength and physical recovery in ARDS survivors, because the
mechanisms underlying these physical impairments and poor recovery are not well understood. The overall
hypothesis of the project is that multi-systemic dysregulation that occurs in acute ARDS, persists after hospital
discharge in those with persistent physical impairment, and resolves in those who recover physically. The overall
objective of the project is to determine whether persistent inflammation from dysregulated monocytes, anabolic
hormone deficiencies, and muscle mitochondrial dysfunction at 3 months after hospital discharge are each
treatment targets for physical disability in ARDS survivors. To achieve our objective, we will conduct a nested
case-control study of cohorts. We will prospectively enroll 345 ARDS survivors at hospital discharge with 12-
month longitudinal follow-up from Johns Hopkins University and Columbia University hospitals. Three months
after hospital discharge, we will conduct an in-person nested case-control study of 180 ARDS survivors, with
case status defined as not-recovered from new disability. Inflammation, anabolic hormone deficiencies, and
muscle mitochondrial dysfunction increase with aging and comorbidity, and older adult ARDS survivors are less
likely to recover than those who are younger and healthier. Therefore, to determine biomarker levels and muscle
mitochondrial dysfunction that are associated with ARDS, independent of age or comorbidity, we will compare
ARDS survivors with carefully matched community-dwelling adults from the National Heart Lung and Blood
Institute (NHLBI) Multi-Ethnic Study of Atherosclerosis (MESA) and the Columbia University Merritt Center
muscle biobank. Across the cohorts, we have carefully coordinated sociodemographic, clinical, and functional
assessments to facilitate careful matching. We will conduct rigorous serum biomarker assessments, targeted
plasma metabolomics, high dimensional flow cytometry of blood, and muscle biopsy mitochondrial function and
gene expression analyses to accomplish our three Aims: (1) to determine the role of monocyte function in
recovery from disability in ARDS survivors; (2) to determine the role of anabolic hormone deficiencies in recovery
from disability in ARDS survivors; and (3), to determine how plasma biomarkers of mitochondrial myopathy
associate with skeletal muscle mitochondrial dysfunction and recovery from disability in ARDS survivors. The
overall goal is to conduct epi-mechanistic studies that will inform future post-ARDS randomized trials of targeted
anti-inflammatory therapies, hormone supplementation therapies, and muscle mitochondrial therapies that aim
to improve physical function in ARDS survivors, a NHBLI research priority.

Public health relevance
PROJECT NARRATIVE Hundreds of thousands of American adults survive Acute Respiratory Distress Syndrome (ARDS) each year, but at least half have persistent muscle weakness that results in increased disability, healthcare costs, and mortality. The project aims to improve long-term physical function in ARDS survivors by elucidating pathobiological processes that differ between ARDS survivors who recovery physically and those who do not as novel treatment targets for post-ICU clinic based trials.